Administrative Core

Project Summary: Core A The Administrative Core provides for essential administration, communication, and compliance responsibilities of the Exploratory Grant. It acts to promote the integration, support the Program Director and Program Administrator, organizes meetings of the Program faculty and staff, and facilitate participation in national external activities. The Administrative Core is directed by the Program Director, Dr. Standaert. He is assisted by the Center Administrator, Ms. Katherine Belue. The Core will be responsible for the coordination of the Program. Although the investigators do have established collaborative interactions, achieving the integration needed for a successful P50 Udall application will require a higher level of integration and interaction among the PI’s, their laboratory trainees and staff, and the broader community of neuroscientists and immunologists who may participate in a P50 application. The approach to coordination will include electronic communication (video conferencing and a web-based content management system for document sharing, messaging, and calendaring) as well as in person meetings. These will include biweekly meetings of the project investigators and their team. The Core will support an annual “mini-retreat” to assist in expanding collaborations beyond the initial Exploratory Grant investigators and achieving the scope required for a successful P50. The Core will oversee sharing, regulatory compliance, and financial management. The Core will establish a web site, to communicate the activities of the Exploratory Program and maintain ties with our community partners. Training is a key component of our plans for a future Udall Center plan. All three project PI’s have current pre- and post-doctoral fellows, and close relationships with important training. We will use the support from the Exploratory Grant to strengthen these connections and promote the participation of trainees and faculty at all levels in the activities of the Exploratory Grant.